NEONATAL TRAINING GRANT

DESCRIPTION (provided by applicant): This training grant requests support for 3 research training positions for 3rd and 4th year M.D. neonatology fellows to develop sufficient research experience to initiate careers in academic neonatology. This training program will supplement the clinical neonatology fellowship that has had 9 to 12 fellows in training at Children's Hospital Medical Center (CHMC) for many years. The training grant will support only those select fellows that demonstrate real research potential and motivation after the first 2 years of fellowship. The research training is structured a mentored experience with the fellow in training working with a senior mentor and often with an associate mentor. All mentors are members of the Neonatology/Pulmonary Biology Division at CHMC and include 6 M.D. clinicians/researchers, 5 M.D./Ph.D. clinicians/researchers and 7 M.D./Ph.D. or Ph.D. researchers that work as a large collaborative group with the common research themes of lung development, and lung injury. The group uses state of the art technology to explore questions in lung biology that range from molecular genetics and transgenic models to lung physiology. The lung research is supplemented by clinical research supported by the NICHD Neonatal Research Network. The goal for this training grant is to support only research training for Neonatologists who have the potential and motivation to become successful research oriented academic neonatologists.